Enhancement of Cancer Research at Clark Atlanta University

PROJECT SUMMARY/ABSTRACT
Clark Atlanta University (CAU) is a comprehensive institution of higher education with a distinct Black-American
heritage, and federally accredited as a historically black college/university (HBCU) by the US. Department of
Education. The Center for Cancer Research and Therapeutic Development (CCRTD) was established at CAU
in 1999 with support from the NIH/RCMI program focused on research in cancer biology, drug discovery and
social/behavioral aspects of cancer. In 2004, CAU focused the research program on prostate cancer and its
impact in the African-American community. In 2005, the Center was designated as CAU’s 1st university-wide
Center of Excellence with the following objectives: A) Develop a group of internationally known scientists that
will execute high-impact basic research in cancer, and contribute in the development of successful therapeutic,
community and translational strategies for cancer; B) Train undergraduate and graduate students, and
postdoctoral fellows in cancer research, and, hence, develop and produce future generations of African-
American scientists of the highest caliber; and C) Establish educational programming to increase awareness for
prevention, early detection and treatment of cancers, especially those which disproportionately affect the African-
American community. As a consequence of targeted recruitment of faculty and staff over the past 19 years,
CCRTD is currently one of the largest centers of its kind in the nation with a unique and comprehensive program
whole dedicated to prostate cancer. We’ve recruited 9 external tenure-track faculty members to CAU with diverse
expertise in biomedical sciences, and have expanded our social/behavioral faculty with 3 faculty from Social
Work (2) and Public Administration (1). To provide state-of-the art research infrastructure, the CCRTD has
developed research core laboratories to support research activities of faculty, staff and students which have
undergone significant expansion throughout the past several years. We are also actively engaged in the research
training and education of both undergraduate and graduate students. Finally, our community education and
outreach unit has established dynamic educational and outreach programs for African-American men, their
families and caretakers, and community-at-large in Southwest City of Atlanta and beyond. The current proposal
seeks to expand and enhance the research agenda and community engagement activities at CCRTD through
(1)transitioning the basic science research to early and beginning translational outcomes, expanding our
research agenda in social/behavior sciences, recruiting faculty in health disparities research, and developing
robust projects in biomedical or social/behavioral research of prostate cancer activities for junior scientists;
(2)acquire new equipment to upgrade the current research core laboratories, renovate space to house new
equipment and current equipment, and renovate data architecture to accommodate new equipment, and data
needs; and (3) improving community engagement to achieve sustainable outcomes, equitable decision-making
processes, and deepen relationships and trust between the community and the CCRTD.

Public health relevance
PROJECT NARRATIVE The incidence of prostate cancer is 1.6, and the mortality rate is 2.5 times higher in African-American men when compared to Caucasian men. The reasons for this increased risk for African-American men are multifactorial social, behavioral, economical, and systemic differences that result in biological tranformities leading to cancer. Combined strategies based on biomedical research, social/behavioral investigations and community engagement are required to combat this disease in the African-American community, and the Center for Cancer Research and Therapeutic Development (CCRTD) at Clark Atlanta University (CAU) is focused on the trilateral approaches to conduct basic research in prostate cancer, train the next generation of scientists in prostate cancer and build trust in the African-American community through engagement, education, outreach, and culturally- sensitive dissemination of our research agenda.